Project 2

PROJECT SUMMARY
Bladder cancer (BC) patients present with non-muscle (NMI) or muscle invasive (MI) disease, and 20% of NMI
progress to MI during follow up with a major reduction in survival. Hence, for this proposal we define early bladder
lesions as non-muscle-invasive bladder cancer (NMIBC) and seek to address the two major clinical gaps in
NMIBC: 1) defining actionable mechanisms of NIMBC progression; 2) risk stratification of NMIBC to patients
likely to progress. Project Integration: Project 1 & 2 address the first gap and provide new markers for Project
3 to address the third. The premise of Project 2, based on prior literature, is that progressing NMIBC harbor
similar cancer cell populations as MIBC. To test this hypothesis, we carried out single nuclei RNA sequencing of
MIBC and identified 18 distinct epithelial and stromal populations based on their unique gene expression profiles.
When gene signature scores of each population were calculated for NMI (N=327) and MI (TCGA) BC based on
their bulk RNA data, high scores of only one malignant epithelial and 2 cancer-associated fibroblast (CAF)
populations associated with progression and survival, respectively. Only prevalence of CAFs expressing
fibroblast activation protein (FAP) stratified outcomes and progression of NMI to MI BC, suggesting FAP+ CAFs
cooperate with this epithelial population to drive progression. Spatial profiling found this epithelial population
proximal to CAFs, and ligand-receptor analysis suggested communication with CAFs, leading us to name these
cells “C3”, for “Cell-Cell Communication”. Interestingly, RNA velocity analysis to computationally decern lineage
relationships in the normal urothelium found cells with C3 gene signatures in a trajectory following basal cells.
Thus, C3 tumor cells may arise from transformation of normal C3 cells during differentiation. Our Specific Aims
test the Hypothesis that NMIBC progression is driven by C3 tumor cell intrinsic properties and C3 interactions
with FAP+ CAFs. In Aim 1 we use lineage tracing of our novel iPSC-based model of normal bladder development
which finds C3 cells and FAP+ fibroblasts emerge during bladder differentiation and spatial proteomic data from
normal bladder to test the hypothesis that C3 cells emerge from basal cells and promote the appearance of
FAP+ fibroblasts. In Aim 2 we examine the intrinsic determinants of transformation/progression of C3 cells using
functional genomics in an autochthonous murine model and human xenograft models of BC to test the hypothesis
that expression of some of 14 candidate C3 driver genes is necessary for carcinogenesis, tumor growth and
progression. In Aim 3 we co-culture human tumor cells with known levels of C3 with normal bladder fibroblasts
and BC CAFs and use murine BC cells implanted intravesically in mice with fibroblast defects in FAP to test the
hypothesis that C3 cells promote FAP+ CAFs, which reciprocally drive C3 expansion in a vicious cycle to drive
tumor growth and progression. Benchmark of Success: Aim 1 draws the first spatiotemporal portrait of a new
cell population in bladder differentiation and serves as a blueprint for how new populations should be evaluated;
Aim 2 & 3 provide candidates to develop for prevention and therapy as well as prediction of NMIBC progression.